Apolipoprotein E glycosylation and its role in Alzheimer's disease pathogenesis

Abstract
Despite the critical importance of the O-glycoprotein apolipoprotein E (APOE) on Alzheimer’s disease (AD) risk,
with the APOE4 isoform increasing risk compared to APOE3 and APOE2 reducing it, the precise mechanism
behind this remains elusive. We have characterized APOE O-glycosylation using our quantitative glycoproteomic
targeted mass spectrometric approach showing that CSF and plasma APOE glycosylation differ greatly,
particularly in the lipid binding domain. We have also developed a range of APOE binding assays to determine
the impact of glycosylation on function. Our data using APOE from induced pluripotent stem cell (iPSC) derived
cells shows that glycosylation alters APOE binding properties. We also know that transferases, the enzymes that
add the monosaccharides to glycans, wane with age and sialyltransferases are reduced in AD and there are
differences in APOE modifications between APOE3.3 and APOE4.4 human brains. Together, this makes it
critical to fully understand APOE glycosylation. Thus, we hypothesize that APOE shows isoform-dependent
glycosylation and that aberrant glycosylation alters APOE binding properties, exacerbating AD
pathogenesis. We will use a range of glycobiology and iPSC techniques to address four Aims. Aim 1 will use
normal APOE isogenic iPSC-derived astrocytes and hepatocytes, the main producers of APOE. We will
characterize their APOE glycoprofiles and associated binding properties, to gain an understanding of tissue and
isoform-specific APOE glycosylation differences and their functional impacts. Transferase expression will be also
analyzed to further determine the mechanisms behind glycosylation differences. Aim 2 will compare astrocytes
derived from healthy and AD APOE isogenic iPSCs and determine how AD alters APOE glycosylation; how this
is altered between APOE isoforms, and how such changes impact APOE functions involved in AD pathogenesis.
Lipoprotein, receptor and Aβ binding will be compared. Finally, we will compare the APOE glycoprofiles of AD
and normal human brain samples to our iPSC data. Aim 3 will use normal APOE isogenic iPSCs to model aging
and AD by two methods to determine which more closely resembles the APOE glycosylation of AD. First by
reducing the specific sialyltransferase expression seen in aging and second by disrupting the Aβ environment
by introducing a known APP mutation. This will elucidate how pathogenic glycosylation changes begin. Aim 4
will address if astrocytes with aberrant APOE glycosylation alter neuronal network activity and amyloid
accumulation by co-culture with iPSC-derived neurons. Our micro-electrode array (MEA) analyses have shown
that the APOE genotype of astrocytes affects neuronal networks. We will use MEAs and measures of Aβ
accumulation to determine the effect of these aberrantly glycosylated cell lines on neurons. Ultimately we will
have characterized normal and AD isoform-specific APOE glycosylation and defined its impact on APOE
functions, especially those relating to AD pathogenesis. We will determine how aberrant APOE glycosylation is
a promoter of Aβ accumulation, AD pathogenesis and neuron network degeneration.

Public health relevance
Project narrative Alzheimer’s disease (AD) has no treatment and drug trials are increasingly focused on earlier AD stages, so we need to better understand and detect early AD pathogenesis. This project focuses on Apolipoprotein E (APOE), the strongest genetic risk factor for AD, using cutting-edge technologies to analyze the entire molecule including its glycosylation (sugars attached to the protein), and how this glycosylation affects the still unexplained role of APOE in the disease process at these early stages. We will use stem cells produced from patient skin samples to understand the functional impact of changes to APOE glycosylation seen in aging and AD and determine their effects on critical characteristics of AD pathogenesis.